The developmental pathway of fetal-derived B cells

Abstract
Stem cell theory states that all the blood cells are derived from hematopoietic stem cells (HSCs) and is a central
concept of hematology and immunology. Bone marrow transplant therapy for blood disorders is rooted in the
concept that donor HSCs can replace all blood cells in the recipient's body. However, recent research has
challenged the stem cell theory by showing that some tissue-resident immune cells develop from endothelial
cells (EC) of the embryo in an HSC-independent manner and these immune cells may not be replaced by HSCs.
Furthermore, it has been reported that a significant percentage of conventional B cells (B-2 cells) also originate
from fetal EC progenitors in the embryo and persist into old mice. These striking results highlight a huge
knowledge gap in the hematology and immunology fields because HSC-independent B-2 cell development has
yet to be recognized. Since B cells play important roles in protecting against infections and in the pathology of
autoimmune and other diseases, it is critically important to understand the developmental pathways of HSC-
independent B-cells and their functions compared to HSC-derived counterparts. However, it is challenging to
clarify the origins of these B-cells since there are multiple waves of hematopoiesis from ECs in the embryo, in
which HSCs and HSC-independent blood progenitors seem to be produced simultaneously. Our preliminary data
and other studies suggest that there are at least three waves of B-cell development; 1) innate-immune B-1 cell
development, 2) common progenitors for innate B-1 and conventional B-2 cells, and 3) B-2 dominant progenitors
derived from HSCs. Our objective is to determine the functional differences of B-cells based on their origins and
to establish a revised B-cell development map from embryo to adult, using combinations of various lineage
tracing and in vivo barcoding mouse models. To pursue these goals, Aim 1 will utilize HSC-labeling mice (100%
labeling of HSCs is achieved) and the HSC-derived lymphoid cell depletion model so that HSC-independent and
dependent B-cell subsets will be separated. Then, these HSC-independent and dependent B-cell subsets will
be sorted and examined for 1) antibody and cytokine secretion, class switching upon in vitro stimulation, and
their IgM repertoire, 2) in vivo repsonse to S. pneumoniae infection, and 3) response to pneumococcal
vaccination. In Aim 2, preliminary data identified the earliest innate-immune restricted B-progenitors in the early
fetal liver. Also, scRNA-sequencing of the neonatal spleen revealed three separate B-progenitor clusters,
supporting our hypothesis. Thus, the EC-lineage tracing mouse model that can mark HSC-independent blood
progenitors will be combined with in vivo barcoding, which will enable visualization of the clonal relationships
between HSCs and fetal- and HSC-derived B-progenitors. The results obtained from this proposal will revise the
current paradigm of B-cell development and will be utilized to understand pathology not previously recognized
in the absence of recognizing the existance of various fetal-derived B cell subsets.

Public health relevance
Project Narrative B-cells play various critical roles in protecting against microbial invasions by secreting antibodies and cytokines, and dysfunction of B-cells causes immunodeficiency, autoimmunity, or leukemia/lymphomas. Emerging evidence has shown that not only innate-immune B-cells but also a portion of adaptive immune B cells originate from fetal progenitors, independently of hematopoietic stem cells. The objective of this project is to develop a landscape of the developmental process of all B cell subsets from fetus to adult, exploring the precise origins and functions, thus, contributing to filling the knowledge gap in B-cell biology.